Epigenetic mechanisms of disrupted neurodevelopment in Menke-Hennekam syndrome

Project Summary
Heterozygous variants in EP300, a histone acetyltransferase, cause two rare multi-organ chromatinopathies:
Menke-Hennekam syndromes type 2 (MKHK2; MIM618333, specifically mutations in exon 30-31) and
Rubinstein-Taybi type 2 (RSTS2; MIM613684). Interestingly, based on “inverse” patient craniofacial
characteristics with RSTS and the alignment of MKHK2 facial features with another disorder with duplicated
regions of CREBBP (EP300's paralog), authors have proposed mutations causing MKHK and RSTS have
potentially different functions (i.e., gain [GOF] versus loss [LOF], respectively).1,2 In addition, individuals with
MKHK2 have overlapping manifestations with disorders with malformations in cortical development (MCD),
such as microencephaly, seizures, intellectual disability, repetitive behaviors, and increased rates of co-diagnoses
with autism spectrum disorder, demonstrating a potential role in cortical neuron function.3 While the specialized
exon 30-31 missense mutations found in MKHK2 have yet to be modeled, RSTS2 LOF models have yielded
phenotypic changes of shorter branches and hypo-excitability. However, the RSTS2 LOF bulk neuronal
bioinformatical analyses contained contaminating cell types with differential regional specificity, therefore,
EP300 specific gene network/pathways are uninterpretable. Together this demonstrates a critical need to
understand EP300's role in maturation and function of cortical excitatory neurons before treatment of MKHK2
neurological issues can be tackled. We hypothesize that MKHK2 EP300 mutation causes accelerated
maturation rate, decreased dendrite formation, and altered neuronal function.
This proposal is a collaboration between Drs. Potter and Barski who specialize in epigenomics and Dr. Tchieu, a
developmental biologist who developed methods for human induced pluripotent stem cell (hPSC) differentiation
into nervous system cell types. In this study, we will use this approach to differentiate MKHK2 mutated EP300
and corresponding isogenic control hPSCs into radial glia-like neural stem cells and PFC excitatory neurons in
order to: (1) identify MKHK2-related defects in neuronal maturation and signaling and (2) to identify epigenetic
and gene expression changes driving them.
This pilot project will provide a solid foundation for the study of the mechanism(s) behind neurocortical
developmental defects in MKHK2 and allow identification of molecular targets for potential therapies for
MKHK2 seizures and other related MCD-like symptoms. Further, we can apply knowledge and technical
expertise gained from this project to other epigenetic proteins to further expand our knowledge of epigenetic
regulation during corticogenesis, specifically neuronal maturation and signaling allowing for a broader impact
on the treatment of MCD, neurodegenerative, neurodevelopment, and neuroinflammatory disorders.

Public health relevance
Narrative: Public Health Relevance. Menke-Hennekam syndrome type 2 (MKHK2, MIM618333) is a rare multi-organ disease caused by heterozygous mutations in an epigenetic regulator, histone acetyltransferase EP300. Currently, no disease-specific, FDA-approved medications are available to treat MKHK2. This pilot study addresses the mechanisms of neurodevelopmental defects in MKHK2 and serves as a platform to investigate potential druggable targets in the future.